Pathobiology of GNAL-Associated Dystonia

Dystonia has recently been redefined as a “movement disorder characterized by sustained or intermittent
muscle contractions causing abnormal, often repetitive, movements, postures, or both.” Dystonia is also a
clinical sign that can be the presenting or prominent manifestation of many neurodegenerative and
neurometabolic disorders. Etiological categories include isolated dystonia, secondary dystonia,
heredodegenerative diseases with dystonia, and dystonia plus. Many cases of isolated dystonia are believed
to be genetic in origin and mutations in GNAL may be the most prevalent known genetic cause of mainly adult-
onset isolated dystonia. GNAL encodes Gα(olf) [major isoform] and XLGα(olf) [long isoform] which are both
expressed in human striatum and cerebellum. The overall goals of our proposal are to use Gα(olf)/XLGα(olf)
deficiency as a bridge to understand the cellular pathobiology of isolated dystonia, and employ conditional
knock-out (cKO) mouse models to explore the neural circuitry that drives isolated dystonia. These goals will be
achieved through three specific aims. First, we will determine the CNS localization of the major and long Gnal
isoforms with cell-type specificity. Second, we will characterize the temporal changes in epigenetic marks
(DNA methylation, histone modifications) and gene expression associated with Gα(olf)/XLGα(olf) deficiency in
indirect pathway medium spiny neurons (iMSNs), direct pathway MSNs (dMSNs), and Purkinje cells (PCs).
Third, we will determine the behavioral effects of Gnal cKO in iMSNs and PCs. Completion of these aims will
radically expand upon our current understanding of isolated and tardive dystonia pathogenesis and
Gα(olf)/XLGα(olf) signaling pathways.

Public health relevance
Mutations in the gene GNAL can cause dystonia, a syndrome of involuntary, sustained muscle contractions affecting one or more sites of the body. Our research will use mouse models and an integrated collection of cellular and molecular approaches to study the mechanisms by which GNAL mutations contribute to the development of dystonia.